Strengthening neuro-cognitive skills for success in school, work and beyond

In order to advance the development of tele-rehabilitation that addresses issues related to traumatic brain
injury (TBI), post-traumatic stress disorder (PTSD), and related issues, this project will deploy and test two
interventions designed to build strengths valuable for achieving personal goals such as in school and work.
The interventions will be based on two different lines of theory for improving goal-directed functioning,
targeting either goal-directed brain state regulation skills (GSR) or knowledge for optimizing brain
functioning (OPT). Both interventions will utilize advances in tele-rehabilitation (e.g., online resources,
digital apps, and coaching over tele-video) to provide access to guided learning experiences for Veterans in
different locations and settings. We will examine the impact of these interventions on multiple levels of
goal-directed functioning, and we will investigate changes in hypothesized neurocognitive pathways.
Post-9/11 Veterans with a history of TBI (age 25-60) will be allocated to one of the two training
interventions in a randomized, controlled design. Assessments will focus on indexing tiers of goal-directed
functioning (neurocognitive tests, functional performance with complex tasks, and goal attainment in
personal life) and will be collected for double-baseline, after training, and at 3 months follow-up.
The knowledge generated by this project will inform Veteran-centered intervention development, including
informing and providing tools for tele-rehabilitation that Veterans can access at home, in school, and other
settings remote from VA facilities.

Public health relevance
As Veterans transition to community, success in achieving school, work and other goals are top priorities. However, difficulties with concentration, memory, irritability and other symptoms of cognitive-emotional dysregulation can ‘derail’ the life paths of Veterans with traumatic brain injury (TBI), post-traumatic stress disorder (PTSD), and related issues. Many Veterans are interested in approaches to building their personal strengths – approaches that help them help themselves. Barriers to care leave gaps for many Veterans. Our overall mission is to help Veterans build strengths for regulating attention, keeping key information in mind, staying on track, and following through despite challenges in order accomplish goals. This project will provide access to learning experiences to improve brain functioning via tele-rehabilitation. The project will inform Veteran-centered care that Veterans can access at home, in school, and in other settings.